Drug Delivery to the Brain: Emerging Modalities

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Drug Delivery to the Brain: Emerging
Modalities, organized by Drs. James Gorman, Stina Syvänen and Danica Stanimirovic (in memoriam) with
scientific programming input from Keystone Symposia. The meeting will take place February 17–20, 2025 at
Keystone Resort in Keystone, Colorado USA.
Recognizing that better treatments are urgently needed for a range of devastating brain diseases, including
neurodegenerative diseases, brain tumors, and rare genetic conditions, this Keystone Symposia conference on
Drug Delivery to the Brain will focus on the development of experimental central nervous system (CNS) disease
therapies and tailoring strategies for their delivery to the brain and spinal cord. The conference program sessions
will showcase scientific advances in understanding barriers for drug delivery, address translational successes
and challenges with in vitro and in vivo models of complex brain transport and disease processes, and provide
updates on and evaluation of clinical trials to guide future studies. This conference is unique in its focus on
scientific and technological advances and challenges in delivering new therapies across a wide range of
modalities to appropriate compartments in the CNS. Additionally, this conference will be held at the same time
and location as another Keystone Symposia conference, Antibodies as Drugs: Innovative Formats, Design and
Engineering, which will offer the unique opportunity for distinct scientific communities with related interests to
share cross-disciplinary insights and encourage new collaborations towards novel treatment and delivery
modalities that can be applied to prevent, treat, and cure a multitude of diseases.

Public health relevance
PROJECT NARRATIVE Despite leading advances in drug development for targeting brain tumors and central nervous system (CNS) diseases (e.g., Alzheimer’s and Parkinson’s diseases), the unique configuration of the nervous system creates challenges for effective delivery of these treatments to the brain or CNS. Research designed to enhance drug access to these regions relies on cross-disciplinary efforts from numerous fields, and to date, few conferences have focused on this important area of drug development. This Keystone Symposia meeting, Drug Delivery to the Brain: Emerging Modalities will provide a unique opportunity to bring together a broad and diverse community of scientists, clinicians, and industrial researchers to cover the most exciting developments in this rapidly advancing field, enabling further acceleration of progress in drug delivery technologies and brain-targeted therapeutics.